UAB CFRC Pilot and Feasibility Program

PROJECT SUMMARY / ABSTRACT
Pilot projects within the UAB P30 Center contribute to multidisciplinary research on our campus, enhance
faculty development, extensively utilize Scientific Cores, and integrate well with the global research themes of
the UAB Center. A strong and well-supported Pilot and Feasibility mechanism has allowed the Center to
address new research priorities and expand its scientific purview. The goals of the P30 Pilot and Feasibility
Component are delineated through four Specific Aims. First, the Pilot Program identifies and supports new
research projects of outstanding quality and innovation. Projects typically last one to two years each, are
concordant with the overall objectives of the UAB P30 and are intended to result in further grant support from
NIH, Cystic Fibrosis (CF) Foundation, or other funding agencies. Second, the Pilot Program supports
promising junior faculty in career development through funding of outstanding pilot research. The Center
Enrichment Program, strong mentoring within the CF Center, a robust Enrichment program, and extensive
training resources available at UAB through the Center for Clinical and Translational Science (UAB’s NIH-
funded CTSA research program) are also employed toward this end. Third, the Pilot Program augments the
breadth and quality of CF research by funding innovative projects from established researchers with valuable
expertise who are new to CF research, or alternatively from established CF investigators who want to test new
high-impact hypotheses. And fourth, the Pilot Program provides an administrative framework for review and
oversight of Pilot and Feasibility Studies. This includes broad solicitation and rigorous peer review of Pilot
applications, recommendations regarding 2nd-year funding of Pilots to the Internal Advisory Committee,
assistance and mentoring to pilot PIs, and record-keeping regarding publication and grant outcomes that result
from pilot funding to provide evidence for continuous process improvement. Overall, the Pilot Program has had
an important impact on CF research at UAB, has been very successful in assisting multiple faculty early in their
careers to successfully obtain extramural funding for CF research, and has enlarged our Research Base in
new innovative directions.